Quantification and Classification of Aqueous and Vitreous Inflammation in Uveitis Using Deep Learning Analysis of Ultrahigh-Resolution OCT

PROJECT SUMMARY
Uveitis is a common cause of blindness in the United States. The specific cause of uveitis is often unknown,
making it difficult to implement targeted testing and treatment. By harnessing the power of artificial intelligence
(AI) and ultrahigh-resolution optical coherence tomography (OCT), we will develop novel tools to help diagnose
and classify uveitis by characterizing the distribution and type of inflammatory response within the eye. OCT
will be used to image multiple areas in the aqueous and vitreous media of the eye and count the density of
inflammatory cells. AI analysis will further classify cell types to aid in differential diagnosis. Protein levels in the
media will be estimated based on the intensity of background scattering. Together, the cell count and protein
level can be used to monitor the patient’s disease severity and response to treatment. The precision of OCT is
ideal for clinical trials, where precise outcome measures can accelerate drug development and save costs. To
further these goals, specific aims of the project are:
(1) Develop ultrahigh-resolution OCT for imaging the anterior and vitreous media of the eye.
(2) Quantify and classify inflammation in the aqueous and vitreous humor of uveitis patients. We will
develop OCT-based biomarkers to aid in the differential diagnosis of uveitis and assessment of
disease severity.

Public health relevance
PROJECT NARRATIVE Uveitis is a group of ocular disorders characterized by increased inflammatory cells and protein levels inside the eye. This project aims to develop novel ways to use optical coherence tomography (OCT), an imaging technology with micrometer precision, to detect, grade, and monitor inflammatory cells and protein levels in the aqueous and vitreous humor of the eye so that proper treatment can be delivered on a timely basis. Artificial intelligence algorithms will be developed to analyze OCT images and differentiate the types of cells suspended in the aqueous and vitreous humor.